Neutrophil-mediated pathways of kidney injury in lupus nephritis

Systemic lupus erythematosus (lupus) is a multi-organ autoimmune disease with 5-10% mortality in 10
years. Both skin and kidney (lupus nephritis, LN) are severely affected and sensitivity to ultraviolet (UV)
sunlight rays affecting ~ 80% of patients can lead to LN flares. The cellular and molecular mechanisms
linking skin inflammation caused by UV light and kidney injury are unknown. The overall objectives in this
proposal are to: (i) demonstrate mechanisms by which neutrophils migrating from UV-exposed skin
damage glomerular and tubular cells to trigger LN flares, (ii) elucidate the role of a novel CD177high
neutrophil population in kidney injury, and (ii) define the role of UV-induced type I interferon (IFN-I)
response on neutrophil interactions with and damage of kidney structural cells, on a single-cell basis. The
central hypothesis is that neutrophils recruited to the kidney following skin UV exposure mediate acute
podocyte and distal tubular loss and injury, and lead to chronic mesangial fibrosis potentiated by type I
interferon. The rationale for this project stems from the gap in the knowledge of how neutrophils mediate
kidney injury in lupus. The central hypothesis will be tested by pursuing two specific aims: 1) Define the
mechanisms of neutrophil-mediated lupus nephritis flares caused by skin exposure to UV light and 2)
Define the role of UV-induced IFN-I on neutrophil interactions with and damage of kidney structural cells.
In Aim 1, single cell RNA sequencing (scRNAseq)of renal structural cells, multiplexed immunofluorescence
staining of the kidney tissue, and kidney proteomics, will be applied to define how neutrophils (e.g.,
CD177hi) injure renal endothelium and epithelium in an autoantibody-mediated and a photosensitive
model of LN. In Aim 2, scRNAseq of kidney structural cells and neutrophils, in the absence of global or
neutrophil-specific IFN-I signaling, will define IFN-I driven genes and pathways, as well as
neutrophil-kidney cells ligand-receptor interactions, involved in UV-triggered kidney injury in LN models.
The research proposed in this application is innovative because it will identify molecular and cellular
targets that link local skin and distal renal injury. The proposed research is significant because it is
expected to provide a strong scientific rationale to target specific pathways of neutrophil-mediated
inflammatory mechanisms and downstream structural cell injury for therapeutic purposes in LN flares.